Scientific Support Services for the NCI/DCCPS

The contractor shall provide all necessary personnel, materials and services to perform all the work in the SOW to support the NCI Division of Cancer Control and Population Science.

Examples of the types of services provided include Data Collection, Data Management, and Data Analysis; Content Analysis, and Public Health Analysis; Portfolio Analysis and Project Evaluation